Continuous neurogenesis in the mammalian hippocampus

As an Administrative Supplement to our current R35 funding, we are proposing to extend our
rigorous and multifaceted analyses of hippocampal neurogenesis in mice and human induced
pluripotent stem cell models to a focused study of human adult neurogenesis in postmortem
hippocampal tissue obtained from age-matched neurotypical donors and Alzheimer’s Disease
(AD) patients. In rodent models of AD, adult hippocampal neurogenesis is reduced, whereas
enhancing adult hippocampal neurogenesis is sufficient to rescue the cognitive deficits. Little is
known about the molecular characteristics of adult hippocampal neurogenesis in humans and in
AD. We have recently completed a study using single-nucleus RNA-seq (snRNA-seq) to
generate a transcriptional signature of human immature neurons in the hippocampus across the
lifespan. Using this signature to profile neurogenesis in hippocampal tissue of the aging brain, in
a pilot study we observed potential differences in both the number and transcriptional profile of
immature neurons in samples from AD patients compared to matched controls. In this proposed
study, we will expand our cohort size to rigorously test our hypotheses of both quantitative and
qualitative changes in adult human hippocampal neurogenesis in the context of AD. Technically,
we will build on our strengths using single-cell approaches to profile both the transcriptome and
chromatin accessibility within the same cell. This combination of snRNA-seq and snATAC-seq
will enhance our ability to identify additional cell types within the neurogenic trajectory and
provide additional information on the epigenetic signatures of AD that may impact neurogenesis.
We will also build on the strength of our machine learning-based analytical approach. Finally,
we will take an integrated bioinformatic approach to combine single-cell profiling, pseudotime
analyses to identify dynamic state transitions, and cellular interactions based on ligand-receptor
expression levels. Together, our study will generate validated single-cell datasets from male and
female AD patients and age-matched controls that will be a valuable resource for the AD
research community and will generate mechanistic hypothesis about AD pathophysiology and
potential therapeutic targets.

Public health relevance
Adult hippocampal neurogenesis reflects the continuous generation of new neurons in the mature brain. The current study will compare the molecular landscape of immature neurons and adult neural stem cells in the hippocampus of AD patients and matched controls.